CORTISOL DEPENDENT REGULATION OF ACTH SECRETORY DYNAMICS

The purpose of this study is to independently assess dynamical components, including pulse duration and amplitude, for individual ACTH bursts, and to compare spontaneous, CRH- and NAL- stimulated ACTH pulses in order to distinguish pituitary and suprapituitary contributions to cortisol-dependent inhibition of ACTH pulse amplitude and duration.